Promoting Safe Transitions from Hospital to Home for Children with Medical Complexity: A Health Literacy-Informed and Family-Centered Approach

PROJECT SUMMARY/ABSTRACT
Children with medical complexity (CMC), or those with multiple chronic conditions, progressive conditions, or
technology dependence, are at high risk for post-hospitalization morbidity. Despite representing 1% of children
in the US, CMC account for 1/3 of pediatric hospital expenditures; 30-day readmission rates are ~20%. Research
on post-discharge morbidity (e.g., adverse drug events, infections, unanticipated visits) has focused on adults.
Few studies have assessed strategies to reduce post-discharge morbidity in CMC. Such strategies must account
for 1) factors distinct to children (e.g., liquid medications, recognizing symptoms in children who cannot express
what is wrong) and 2) specific needs of CMC (e.g., medical equipment, knowing which of many providers to
contact, managing multiple chronic medications, complex family/household dynamics). Inadequate provider-
parent communication and low parent health literacy contribute to poor comprehension of and adherence to
discharge instructions, increasing risk for post-discharge morbidity. Despite recommendations from multiple
national organizations for evidence-based, health literacy-informed interventions to improve communication
processes, to date, a health literacy-informed approach to address post-hospitalization morbidity for CMC has
not been used while also incorporating principals of family dynamics.
The primary objective of this application is to support Dr. Glick’s goal of becoming an independent investigator
with the aim of improving 1) parent comprehension of/adherence to discharge instructions and 2) post-discharge
outcomes for CMC. This goal will be achieved through training from an expert multidisciplinary mentorship team
and formal coursework. He will gain advanced skills in 1) qualitative/mixed method research, 2) family dynamics,
3) user-centered design, and 4) implementation science/design and evaluation of complex interventions. Dr.
Glick will accomplish his goals at NYU School of Medicine through the following 3 aims:
In Aim 1, Dr. Glick will use qualitative methods to examine barriers/facilitators for a) parents in comprehension
of/adherence to discharge instructions and b) pediatricians in providing optimal discharge education for CMC.
In Aim 2, Dr. Glick will use Aim 1 findings, multiple rounds of usability testing, multi-disciplinary workgroups, a
national sample of discharge instructions for CMC, and an existing tool designed to improve parent adherence
to discharge instructions for common pediatric diagnoses to inform the design of his new tool for CMC.
In Aim 3, Dr. Glick will utilize a randomized controlled trial to examine this tool’s efficacy in improving parent
comprehension of and adherence to discharge instructions and reducing post-hospitalization morbidity for CMC.
Successful completion of this project will lead to an R01 application to test the efficacy of the intervention, now
linked to the electronic health record, in improving parent comprehension of/adherence to discharge plans and
reducing post-hospitalization morbidity for CMC.

Public health relevance
PROJECT NARRATIVE Despite representing only 1% of all children in the US, children with medical complexity (CMC) account for one third of hospital expenditures and have 30-day readmission rates of 20%. The overarching goal of this study is to design a heath literacy-informed tool and test its efficacy in improving parent comprehension of/adherence to discharge instructions and reducing post-hospitalization morbidity for CMC. This study has the potential to transform discharge processes for CMC, providing a model for a family-centered, evidence-based, scalable approach to achieve National Academy of Medicine goals of safe, effective, patient-centered, and equitable transitions.